Task A86: THERAPEUTICS TESTING IN MURINE MODELS OF FUNGAL INFECTIONS

This contract provides for the development and standardization of small animal models of infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.